Abnormal mitochondrial-endolysosomal contacts in AD

PROJECT SUMMARY / ABSTRACT
Alzheimer’s disease (AD) is one of the most common neurodegenerative disorders among the aged population. Studies
showed the critical impacts of apolipoprotein E (APOE) ε4 isoform on susceptibility and pathogenesis of late-onset AD
(LOAD). APOE proteins modulate amyloid beta (Aβ) in extracellular plaque formation in an isoform dependent manner.
Mitochondrial deficits were also shown associated with risk APOE ε4 and Aβ in AD. The interplay of APOE ε4 and Aβ likely
modulates the inter-organelle crosstalk, which justifies the investigation into such crosstalk in AD pathogenesis. The pilot
study found increased contacts formed between mitochondria and endolysosomal system in AD neurons compared to
non-AD controls, both in human brain and the mouse model. Furthermore, many more contacts were observed among
human AD APOE ε4 carriers than in AD APOE ε3 carriers. In vitro studies showed APOE AD risk isoform affected the mito-
endolysosomal contacts and mitochondrial Aβ levels and identified STARD3 as an important mediator. These exciting data
unveiled a novel abnormality in mito-endolysosomal contacts, which was associated with APOE ε4 regulated Aβ toxicity
in AD. Therefore, we hypothesized that APOE ε4 caused abnormally increased mito-endolysosome interaction and mi-
tochondrial translocation/accumulation of Aβ through enhanced interaction with STARD3 which led to mitochondrial
dysfunction and neurodegeneration in sporadic LOAD. To test this hypothesis, the detailed examination of the mito-
endolysosomal contact by in vivo and in vitro AD models is required. The long-term goal of this study is the pursuit of
abnormal inter-organelle crosstalk that likely underlies mitochondrial dysfunction and neuronal degeneration in LOAD. In
this regard, the efforts will strive to decipher these three specific aims: 1) whether and how the abnormal crosstalk be-
tween mitochondria and endolysosomal system causes mitochondrial deficits, 2) what is the role of the interplay of APOE
ε4 and its endosomal cargo Aβ in such inter-organelle crosstalk, 3) whether the underlying mechanism supports a thera-
peutic potential for AD. The proposal will focus on the pathogenesis in general sporadic AD population associated with
common AD risk APOE isoform. Importantly, the proposed novel mechanism will also pave the road for discovery of a yet
uncharacterized therapeutic target for common AD population.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction is one of many prominent features of Alzheimer’s disease. Abnormal crosstalk between mitochondria and other cellular organelles were shown to play critical role in AD pathogenesis. The current application focuses on such abnormal inter-organelle crosstalk in AD neurons, which will provide novel mechanistic insights in AD pathogenesis and likely produce novel therapeutic targets for AD.